NMR Spectroscopy of Iron-Sulfur Proteins

Iron-sulfur proteins are ubiquitous in nature and essential to life. Members of this class of metalloprotein play critical roles in biochemical processes ranging from respiration and detoxification to gene regulation and chemical sensing. Defects in iron-sulfur proteins are linked to a large number of human diseases. The electronic properties of iron-sulfur proteins, which impact on their function, are modulated by the geometry of their iron centers and by interactions between electrons on the metal(s) and the ligands provided by the protein. Our overall goals are to determine how protein-protein interactions facilitate iron-sulfur cluster assembly and modulate electron-nuclear interactions at the active sites of iron-sulfur proteins so as to facilitate electron transfers. Our experimental approach to understanding sequence-structure-function relationships in iron-sulfur proteins combines NMR spectroscopy and quantum chemical calculations with information from X-ray crystallography. NMR spectra contain exquisitely sensitive information about electron- nuclear interactions. This information, which is unavailable from X-ray crystal structures, provides insights into the chemical properties of the iron centers, details of their geometry, strengths of hydrogen bonds, proton affinities, and patterns of electron delocalization. NMR thus serves as a window for viewing the properties of the cluster that control redox potentials and regulate pathways of electron transfer and redox dependent changes in pKa values. In the past, we have applied this approach to investigations of single iron- containing proteins and proteins that interact with them. We propose here to extend these investigations to biologically important protein-protein complexes that involve iron centers. Our specific aims are:(1) to determine the mechanism of coupling between proton and electron transfer in the Rieske protein from Thermus thermophilis;(2) to determine how protein:protein complexes affect electron-nuclear interactions and to determine mechanisms of electron transfer in three model biological systems (rubredoxin:FNR, stearoyl-acyl carrier protein desaturase, and toluene monooxygenase system);(3) to determine mechanisms of chaperone-assisted iron-sulfur cluster assembly in Escherichia coli. To achive these aims, we will make use of state-of-the-art approaches to protein production and isotopic labeling, NMR data collection and analysis, modeling of structures and complexes, and quantum chemical calculations.